Novel Role of SEL1L-HRD1 ERAD in Neurodevelopment

Novel Role of SEL1L-HRD1 ERAD in Neurodevelopment
ABSTRACT
Endoplasmic reticulum (ER)-associated protein degradation (ERAD) is a principal mechanism for the recruitment
and retro-translocation of misfolded ER proteins for cytosolic proteasomal degradation. The SEL1L-HRD1
protein complex represents the most conserved branch of ERAD, where SEL1L is an obligatory cofactor for the
E3 ligase HRD1. Despite recent advances in mouse models, its relevance and significance in humans remained
largely unexplored. Recently, we identified four bi-allelic SEL1L and HRD1 hypomorphic variants from 11 human
patients presenting with moderate to severe intellectual disability, microcephaly, developmental delay and
locomotor dysfunction starting in infancy, collectively termed ERAD-associated neurodevelopmental disorder
with onset in infancy (ENDI). This indicates a critical role for SEL1L-HRD1 ERAD in neurodevelopment. Our
preliminary data showed that mice expressing a hypomorphic SEL1L variant (Sel1LS658P) exhibit growth
retardation, microcephaly, hindlimb clasping, and locomotor dysfunction, closely mirroring the symptoms of ENDI
patients. Notably, E16.5 Sel1LS658P embryos exhibited a thinner cortex and disorganized cortical structure,
pointing to a possible role of SEL1L-HRD1 ERAD in corticogenesis. Mechanistically, using a non-biased
proteomics screen, we found that Astrotactin 1 (ASTN1), a neuronal adhesion molecule required for glial-guided
migration of young postmitotic neuroblasts, interacts with SEL1L and is a putative ERAD substrate. Based on
these findings, I hypothesize that SEL1L-HRD1 ERAD plays a critical role in neurodevelopment, as least in
part, by regulating the biogenesis of the neuron migration-related adhesion molecule ASTN1 in the ER.
Using various mouse models powered by state-of-the-art imaging and biochemical techniques, I will accomplish
the following two Aims: Aim 1. Determine the (patho)physiological importance of SEL1L-HRD1 ERAD in
neurodevelopment; Aim 2. Delineate the molecular mechanism of SEL1L-HRD1 ERAD in neurodevelopment.
This study will not only define a new ER quality-control pathway in neurodevelopment and elucidate new
regulatory mechanism underlying the biogenesis of a key neuron migration-related adhesion molecule, but also
provide a framework for the future study on SEL1L-HRD1 ERAD in various complex brain functions and disorders.
The outlined career development plan, including hands-on training, coursework, and meetings/seminars, will
allow me to achieve my long-term goal of becoming an independent investigator in the interdisciplinary cell
biology-neuroscience fields.

Public health relevance
NARRATIVE SEL1L-HRD1 endoplasmic reticulum (ER)-associated degradation (ERAD) is the principal mechanism for the recruitment and retro-translocation of misfolded ER proteins for cytosolic proteasomal degradation. Excitingly, we found that both patients and mice carrying biallelic hypomorphic ERAD disease variants present neurodevelopmental deficiency. I will test the hypothesis that SEL1L-HRD1 ERAD plays a critical role in neurodevelopment, as least in part, by regulating the biogenesis of the neuron migration-related adhesion molecule ASTN1 in the ER.